Developmental Core

DEVELOPMENTAL CORE PROJECT SUMMARY
The mission of the UCSF-Bay Area CFAR is to promote multi-disciplinary HIV research, and the
Developmental Core plays a central role. The Core is the principal vehicle CFAR uses to support investigators
across the CFAR, with a particular focus on early stage investigators (ESI) and investigators from
underrepresented minority (URM) backgrounds. From 2011-2021, CFAR funded 170 pilot awards for a total of
$8.64M, resulting in $156M in follow-on funding from NIH, a 17-fold return on investment. These 170 awards
yielded 525 resultant publications, 17 K-level awards, 15 R21s, 27 R01s and 20 other NIH awards. Of 23
supplements awarded in the last decade, totaling $3.8M, NIH funding was $82.2 million, a 21 times return on
investment. Since our last renewal, the Core has mentored 87 early stage investigators (ESIs) in its formal
Mentoring Program; launched the first CFAR-sponsored Mentoring group to support URM ESIs in HIV
Research; trained 156 researchers in our innovative “Mentoring the Mentors” program on techniques of
effective mentoring focused on diverse mentees (226 since the inception of the workshop in 2012); and
completed a long-term evaluation of both the local mentoring program and the national Mentoring the Mentors
program. During this project period, CFAR funded 72 awards (2 co-funded) in a direct costs amount of $3.1M.
Going forward, the Developmental Core will advance its dedicated commitment to supporting emerging
leaders in HIV research with a heightened focus on diversity, equity, and inclusion through a comprehensive
set of activities centered on four specific aims: (1) to sustain and refine a comprehensive two-year mentoring
program for early career HIV investigators, providing each with access to the tools needed for future success in
research. This CFAR Mentoring Program pairs mentees with senior CFAR mentors, provides monthly career
developmental workshops, hosts a yearly symposium with Excellence awards, provides a yearly leadership
retreat, and provides specific aims reviews before each grant deadline; (2) to conduct annual “Mentoring the
Mentors” workshops to train HIV researchers from CFARs around the U.S. in tools and techniques of
mentoring with a special emphasis on nurturing diversity. We have also traveled to other CFARs to provide this
Mentoring the Mentors workshop and provided programs on mentoring programs for URM trainees in other
forums; (3) to support innovative research and the development of ESIs through four different types of peer-
reviewed awards; and (4) to advocate for and support URM investigators in navigating barriers in academia,
and provide them with key career, mentoring, and professional development support, including forming the first
inter-CFAR working group for URM investigators. Therefore, the revised and expanded Developmental Core
of the UCSF-Bay Area CFAR will continue to be at the center of driving innovation in HIV research locally,
nationally, and globally.